Microvascular Neuroimaging in Age-related Alzheimer's Disease and Tauopathies

PROJECT SUMMARY / ABSTRACT
Ning Hua, PhD, is an MRI scientist whose overarching career goal is to become an independent investigator in
the field of microvascular dysfunction and its relationship to Alzheimer’s disease (AD) and aging brain. The
proposed K01 research combines advanced in vivo dynamic contrast enhanced (DCE)-MRI and novel ex vivo
Laser Ablation Inductively Coupled Plasma Mass Spectrometry (LA-ICP-MS), and aims to explore how trauma-
induced hippocampal microvascular injury accelerates memory deficits, AD-related pathology, and white matter
degeneration. Candidate: Dr. Hua is an Assistant Professor at the Department of Radiology of Boston University
(BU), Chobanian & Avedisian School of Medicine. She gained her PhD in Biophysics, and her previous training
was focused on cardiovascular MRI and arterial atherosclerosis. This K01 proposal will build on her previous
training in MRI, programming, and vascular biology, with 4 training goals to facilitate her transition into
neuroimaging and neurodegenerative diseases and towards career independence: 1) Learn the biology and
pathology underlying AD; 2) Learn relevant experimental skills in neurotrauma and AD mouse models; 3)
Advance her skills in neuroimaging; 4) Prepare for independent research and career track.
Mentors/Environment: Dr. Hua and her primary mentor, Lee E. Goldstein, MD, PhD, have assembled a strong
mentor/advisory team to guide her through the K01 training and research activity. The proposed plan will
leverage resources of the newly established Center for Translational Neuroimaging (BU) and the NIH-NIA
supported BU Alzheimer’s Disease Center. BU and the Department of Radiology are committed to supporting
junior faculty through internal funding, administrative assistance, and structured opportunities. Research:
Currently, it is unclear if blood-brain-barrier (BBB) dysfunction is a mechanistic driver for the acceleration of AD
after neurotrauma. I hypothesize that hippocampus is vulnerable to neurotrauma, and that resulting hippocampal
microvascular leakage will accelerate local accumulation of amyloid-β and phosphorylated-tau, as well as
accelerate white matter degeneration, ultimately leading to accelerated memory deficits in AD. The experiments
will be carried in a well-characterized transgenic mouse model of AD (3xTg-AD) with and without well-calibrated
traumatic brain impacts. In vivo MRI measured hippocampal leakage will be correlated with memory deficits
measured by Barnes Maze test (Aim 1). Ex vivo LA-ICP-MS measured subregional BBB leakage in hippocampus
will be correlated with regional accumulations of amyloid and tau pathology (Aim 2). Finally, ex vivo diffusion
MRI will be used to assess how hippocampal injury accelerates white matter degeneration, especially in the
white matter bundles connecting to the hippocampus and playing an important role in memory and learning (Aim
3). Summary: This K01 proposal utilizes advanced imaging techniques to detect hippocampal BBB leakage,
and its relation to the acceleration of AD. It will facilitate Dr. Hua’s career transition to independence in the
research of neuroimaging and AD.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury may accelerate the development of Alzheimer’s disease, yet its underlying mechanisms are not fully understood. Here I address this unmet need by investigating trauma-induced hippocampal microvascular injury using advanced neuroimaging methods, including brain MRI and laser ablation inductively coupled plasma mass spectrometry (LA-ICP-MS) imaging. My goal is to explore the role of hippocampal blood-brain barrier leakage in the acceleration of amyloid-beta and phosphorylated-tau pathology, white matter degeneration, as well as memory deficits.